Improving pain management and opioid safety through a systemwide, data driven evaluation of the CDC opioid prescribing guideline best practices and the use of Clinical Decision Support

Project Summary
Effectively treating pain while safely prescribing opioid pain medicines is a public health priority.
The CDC opioid prescribing guidelines are an evidence-based approach to decreasing unnecessary opioid
exposures, high-risk opioid use and abuse. The 2016 version produced modest improvements, but were
sometimes misapplied for unsafe opioid tapering; highlighting the challenges of implementation and
changing provider behavior. With guideline updates expected soon, there is a need for prospective trials
to identify strategies to efficiently and effectively deliver CDC guideline recommended practices while
documenting their impact on patient centered outcomes (e.g., pain control, morbidity and mortality).
Clinical decision support (CDS) is a promising implementation strategy to both operationalize
evidence-based practices and maximize the value of routinely collected data. We will use electronic
health record (EHR) embedded CDS to modify clinical behavior toward CDC guideline-concordant
recommendations. We propose a hybrid effectiveness-implementation trial using accepted
implementation science frameworks PRISM (Practical, Robust Implementation and Sustainability Model)
and RE-AIM (Reach, Effectiveness, Adoption, Implementation and Maintenance) to consider the
multilevel contextual factors that influence implementation success. By developing a data-driven
learning health system with the ability to evaluate patient outcomes through linkages to Prescription
Drug Monitoring Program, insurance claims and death data, this project will evaluate:
(1) The effectiveness of CDC guideline-concordant prescribing by describing the association between
guideline concordant actions and patient outcomes.
(2) The user-centered design of EHR based CDS to facilitate CDC guideline concordant actions and
promote non-opioid approaches to pain management.
(3) The evaluation of the implementation and effectiveness of CDS strategies to deliver guideline-
concordant care in a pragmatic cluster randomized trial in a large, integrated health system. We will
systematically assess key implementation outcomes and then evaluate the effectiveness of CDS on
patient outcomes (vs usual care).
This pragmatic research will address the need to link provider prescribing actions to individual
patient outcomes. Using established implementation science approaches to evaluate CDS as an
implementation strategy is innovative and important. Our results will provide robust data to document
the effectiveness of CDC guideline concordant prescribing and evaluate an emerging, scalable
implementation strategy using existing data to decrease morbidity and mortality from the opioid crisis.

Public health relevance
Project Narrative Improving primary prevention of opioid use while effectively treating pain is a pillar of the NIDA HEAL response to the opioid crisis that would benefit greatly from research producing actionable data. The CDC opioid prescribing guidelines (update late `22) define evidence-based practices to improve opioid related morbidity and mortality by decreasing opioid exposures and high-risk opioid use, but lack robust effectiveness data. This single system research project will support the development of EHR based clinical decision support tools to promote CDC guideline recommendations followed by an evaluation of patient centered outcomes by linking provider prescribing to existing Prescription Drug Monitoring Program, insurance claims and death data sets.